Impact of Cigar Flavor in Dual Users: Critical Life Event Supplement

Contact PD/PI: Mead, Erin Lucia
PROJECT SUMMARY/ABSTRACT
The rapid increase in popularity of dual use of flavored little cigars/cigarillos (LCCs) with cigarettes among
U.S. young adults has significant implications for their health, addiction, and cessation. LCCs are used for two
primary reasons: their relatively lower cost and flavor offerings. As cigarettes become more expensive or less
reinforcing, young adults may substitute with attractively flavored LCCs rather than quit. We do not know the
addictiveness of LCCs compared with cigarettes in dual users, the role that flavors play in addiction and dual
use, and if flavors are more important for women than men. Moreover, the FDA has described research on
cigars and flavors as a priority. Therefore, a critical need exists to characterize the addiction potential (AP) of
flavored and unflavored LCCs compared with cigarettes and differences by sex in dual users.
The specific aims are to: (1) characterize the AP of LCCs compared with cigarettes; (2) determine the
extent to which the AP of LCCs varies by flavor and sex of user; and (3) determine the extent to which LCC
use in the home environment differs by flavored vs. unflavored. The proposed study will employ a 3-week
crossover design that combines survey-based measures (including behavioral economic assessments),
biomarkers, and ecological momentary assessments (EMAs) of AP, dependence, and tobacco use behaviors
among 145 non-treatment-seeking young adult (18-34 years old) dual users. AP will be characterized by
behavioral economic indices of demand, such as the hypothetical consumption of LCCs at escalating prices,
and other standardized measures of addiction. The impact of flavors on LCC and cigarette smoking at home
will be captured by EMA. This information will address the following FDA priorities: impact of changes in LCC
flavors on dependence and dual use behaviors, and innovative methods to assess tobacco use behaviors.
The career development plan combines mentored hands-on training with coursework and professional
development activities to meet the objectives critical to my transition to independent tobacco regulatory
scientist. My career goal is to conduct research that develops our understanding of tobacco use in vulnerable
populations, and informs tobacco regulation to reduce disease. I propose additional training in addictions
research (including clinical trials), measurement of dependence and addiction potential, cigar regulatory
research, and grantsmanship. With this training and my prior experience, I will be able to transition to an
independent investigator of tobacco product flavorings and other characteristics that—with cognitive, affective,
behavioral, and environmental influences—contribute to their uptake, use, and addiction. UConn Health,
Brown, and Rutgers provide excellent resources for my career development, including formal coursework,
seminars, expert faculty, research centers, office space, equipment, software, and data collection, analysis,
and management resources. The focused training provided by this Award represents the final step in my
career development and provides preliminary data and training for planned R-level grant writing.
Page 6
Project Summary/Abstract

Public health relevance
Contact PD/PI: Mead, Erin Lucia PROJECT NARRATIVE The dual use of little cigars/cigarillos (LCCs) and cigarettes is a significant public health concern for young adults' health and tobacco addiction. Among young adult dual users, this study compares the addiction potential of LCCs to cigarettes and determines if flavors enhance the addiction and if women are especially susceptible. Results can be used to better inform LCC regulation and cessation programs for this high-priority population. Page 7 Project Narrative